Neuroendocrine Tumor Specialized Programs of Research Excellence (SPORE) in Human Cancer

Overall – Summary
Neuroendocrine tumors (NETs) and neuroendocrine carcinomas (NECs) are orphan cancers whose incidence
and prevalence are increasing in the US. NETs are slow-growing, yet relentlessly progressive and are
notoriously resistant to chemotherapy. The University of Iowa is one of only a handful of institutions where
patients with NETs and NECs are diagnosed, treated, and followed comprehensively over time by an
interdisciplinary team that includes both clinical and laboratory-based investigators with a focused interest in
these tumors. This SPORE will support innovative translational NET research through three projects:
1. Project 1 is a multi-institutional investigation of a new strategy to sensitize pNETs to immune
checkpoint inhibitor (ICI) therapy culminating in a Phase 1b window of opportunity trial combining
CDK4/6 inhibitor therapy with ICI therapy in pNET patients.
2. Project 2 combines pre-clinical metabolic studies of radiation-induced lipid peroxidation with a Phase 1
alpha-emitter radiation therapy trial using 212Pb Pentixather targeting C-X-C Receptor 4 (CXCR4) in
lung NETs and NECs.
3. Project 3 is a timely investigation of the tumor-promoting potential of GLP1 and GIP receptor agonists
in gastroenteropancreatic NETs as those agents have burgeoning clinical use and unprecedented
levels of patient interest.
The Iowa NET SPORE will support translational investigators through four interactive cores:
A. The Administrative Core facilitates communication and collaboration between projects, cores, external
colleagues, advisors and patient advocates.
B. The Biospecimens Core provides access to multiple sources of rare NET tissue and guides scientific
use and accurate tumor classification.
C. The Biostatistics Core provides study design, data analysis, quality control and biostatistics education.
D. The Clinical Core provides access to data in the NET Registry on >2,400 identified patients eager to
participate in trials as well as clinical trial coordination and regulatory support to projects.
We will recruit NET translational researchers via developmental research and career enhancement programs
that successfully transition junior scientists to independent funding and introduce established scientists to the
NET field. Together with patients, we will promote translational research in NETs through vertical and
horizontal collaborations that will lead to improved management of patients with NETs and NECs.
IMPACT: Achievement of these goals will result in scientific advances related to NETs and other cancers,
translation of novel molecularly targeted therapies for patients with NETs and NECs, alteration in patient
management, and prolonged as well as improved quality of life for patients with NETs and NECs.

Public health relevance
Overall – Narrative The number of persons diagnosed with neuroendocrine tumors (NETs) has risen dramatically in the United States. Iowa NET researchers are conducting population-based studies and clinical trials to improve patient outcomes, investigating the impact of increasingly used diabetes and obesity drugs (incretin mimetics) on NET growth, and probing novel targeted therapies that deliver a killing blow to tumor cells while sparing normal tissues. The proposed innovative approaches and therapies should be applicable to other chemotherapy resistant and/or immunologically “cold” cancers, such as prostate and breast, as well as tumors that express high levels of receptors for the incretin mimetics.